Administrative Core

STAT3 Variants as a Rheostat of Immune Tolerance Administrative Core
Project Summary
A strong Project (P01) collaboration requires key centralized organizational structures to foster lab-to-lab
interactions. The Administrative Core will provide the infrastructure required for efficient completion of the
combined project goals. As detailed in the Research Plan, each of the three proposed projects has
contributions from investigators representing two separate institutions. A strong administrative hub,
represented by the Administrative Core, is an essential part of the P01 to make this inter-institutional approach
successful. This Administrative Core serves to faciliate everything from managing videoconferencing and face-
to-face meetings to coordinating regulatory requirements and practical considerations for sharing of research
samples. By supporting scheduled recurring meetings, the core will function to ensure efficient data transfer
and updates on project progress. The success of an individual investigator's planned contributions may hinge
on the results or samples generated from another investigator. The core will function to ensure that information
and specimens are transferred in an efficient manner as to not delay the planned timelines.